Impact of combined nutrition, responsive parenting, and health intervention on childhood development (BUNDLE) study

PROJECT SUMMARY
Children living in resource-limited settings face multiple adversities in their environment which can be
detrimental to their growth and development. Important among these are a lack of responsive parenting
practices and early learning opportunities, poor nutrition and feeding practices, and high incidence of infectious
diseases including diarrhea and malaria. The developmental potential realized if lack of responsive stimulation,
malnutrition, and infection in young children are all addressed is unknown. Our study will test whether early
childhood development in Liberia is improved by a bundled set of interventions that promote responsive
stimulation and improved feeding by the provision of eggs and dried fish (nutrient-dense animal-source food)
integrated into existing infection control activities of the national health system, and whether, in combination,
these stimulation and feeding interventions will be more effective than responsive stimulation alone and the
provision of animal-source foods alone. Our study will build on Plan International Liberia’s longstanding
community-based intervention-delivery platform. In Bomi, Lofa, Nimba, and Margibi counties, we will rigorously
test the effects of a 9-month group-based bundled intervention for female and male caregivers integrated into
existing health services and delivered by trained adult community members on development of children 6 to 30
months of age. Using a four-arm 2x2 factorial cluster-randomized effectiveness design, rigorous intent-to-treat
longitudinal models, and context-validated measures, we will compare cognitive, language, socio-emotional,
and motor development of 2160 children from 144 communities randomized to a comparison arm or one of
three intervention arms. Each arm will receive the national infection control activities. Three intervention arms
will also receive: 1) responsive stimulation, 2) provision of eggs and dried fish for consumption by the children,
or 2) responsive stimulation + provision of eggs and dried fish. Our study has three aims. First, we will test
differences in child development (cognitive, language, socio-emotional, and motor) among children receiving
the national infection control intervention (Arm 1), that intervention plus responsive stimulation (Arm 2), that
intervention plus eggs and dried fish (Arm 3), and all interventions combined (Arm 4). Second, we will test the
impact of the interventions on intermediate outcomes of the child (e.g., anthropometry, consumption of eggs
and fish, morbidity) and caregivers (e.g., early learning opportunities, responsive feeding, responsive
stimulation, mental health, social support, co-parenting) and whether improvements in the intermediate
outcomes mediate effects on child development. Third, we will determine the cost-effectiveness of each
intervention alone and of the full integrated intervention. We hypothesize that child development will be
improved in Arms 2, 3, and 4 compared to Arm 1, and in Arm 4 compared to Arms 2 and 3. This study will
provide conclusive evidence of the effectiveness of a bundled intervention with implications for policy and
programs aimed at improving child development.

Public health relevance
PROJECT NARRATIVE In resource-limited settings, the developmental potential realized if lack of responsive stimulation, malnutrition, and infection in young children are all addressed is unknown. Our study will test whether early childhood development in Liberia is improved by a combination of interventions that promote responsive stimulation and improved feeding by the provision of eggs and dried fish (nutrient-dense animal-source food) integrated into existing infection control activities of the national health system, and whether, in combination, these stimulation and feeding interventions will be more effective than responsive stimulation alone and the provision of animal- source food alone. Our findings will provide conclusive evidence of the effectiveness of an integrated intervention that will have implications for public policy and programs aimed at improving child development.